Ultra-low Fouling and Anti-infective and Anti-thrombotic Nitric Oxide Releasing Intravascular Catheters

Abstract
Nytricx is developing a new class of Nitric Oxide (NO)-releasing intravascular medical catheters to combat
infection and thrombosis associated with indwelling vascular catheters. NO gas is a natural anti-infective and
anti-thrombotic human product principally released from blood vessels and immune cells. Nytricx NO-releasing
technology to the catheter surfaces via a polymer matrix, mimics the natural release by cells to prevent infection
and thrombosis. The Nytricx technology is designed to combine anti-infective and anti-thrombotic properties of
Nitric Oxide (NO) release at the internal and external catheter interfaces, which may be an extremely effective
means to prolong catheter life, decrease chronic infection, and blood clotting (thrombosis) associated with
intravascular catheters. The combination of a novel topcoats with NO gas release from the base silicone polymer
is unique, especially considering that the NO donor itself stays embedded in the polymer with only the NO gas
escaping to affect the external and internal catheter environments. The topcoat also affects biofilm formation
which is also a chronic problem associated with catheter infections preventing effective antibiotic therapy. Nytricx
NO-releasing technology represents a disruptive innovation that will result in saving patients’ lives and cutting
medical costs, especially those related to hospital acquired blood steam infections and thrombosis, associated
with intravascular catheters.

Public health relevance
Narrative Nytricx is developing a new class of Nitric Oxide (NO)-releasing intravascular medical catheters to combat infection and thrombosis associated with indwelling vascular catheters. Nytricx NO-releasing technology represents a disruptive innovation that will result in saving patients’ lives and cutting medical costs, especially those related to hospital acquired blood steam infections and thrombosis, associated with intravascular catheters.